Microbial adaptation of Pseudomonas lipid A structure in CF airway disease progress

PROJECT SUMMARY
Persistent acute inflammation and chronic infection are hallmarks of Cystic Fibrosis (CF) pulmonary disease.
Bacterial infections cause much of the damage seen in CF patients’ airways. Chronic colonization by Pseudo-
monas aeruginosa (Pa) is strongly associated with disease progression and mortality due to the activation of
the host innate immune system. Innate immune cells drive this strong inflammation but paradoxically fail to
clear pathogens such as Pa. We have previously shown that Pa isolated from children with CF have unique
lipid A structures; one of the earliest adaptations to the CF airway. Lipid A is the membrane anchor of lipopoly-
saccharide (LPS) and is responsible for endotoxemia, localized tissue destruction, and septic shock. In addi-
tion to early adaptation to the CF airway, a highly pro-inflammatory, hyper-acylated lipid A structure is ob-
served in approximately one third of Pa isolated from patients with severe airway disease. The synthesis of
specific lipid A structures is essential to CF lung disease pathogenesis as products of inflammation, derived
from infiltrating host immune cells, such as neutrophils, are required for Pa to grow anaerobically in the thick
and poorly oxygenated mucus of the CF lung. The overall goals of this proposal will strengthen and extend our
hypothesis that during adaptation to the CF airway, Pa synthesizes CF-specific lipid A that alters host
innate immune mechanisms, leading to persistence and chronic infection of the CF airways and that
regulation of the neutrophil response could serve as a control mechanism for severe airway disease. The aims
in this proposal will first, determine pathogenicity and signaling potential of defined Pa lipid A structures in rele-
vant mouse models and CF bronchial epithelial cell lines and, second, map and assign structure to pro-inflam-
matory Pa lipid A as it accumulates and distributes during the onset of lung pathology using mass spectrometry
imaging. By defining how Pa lipid A structures condition the host for persistence, we will identify novel host-
directed therapy (HDT) targets.

Public health relevance
PROJECT NARRATIVE Cystic Fibrosis (CF) is a genetic disease that affects more than 70,000 people worldwide and is characterized by the build up of thick mucus in patients’ lungs that traps bacteria (including Pseudomonas aeruginosa, Pa), leads to chronic infection, and progresses to death due to respiratory failure. This proposal will help close gaps in knowledge about which components of the CF-specific Pa LPS structure promote an inflammatory response, and how LPS structure alters the cellular immune response, with an aim toward developing new therapeutic targets.